Stanford Cardiovascular Summer Research Training Program for Medical Students

The objective of the Stanford Cardiovascular Summer Research Training Program for Medical Students is to provide meaningful ten-week summer research experiences to a cohort of 15 first-year medical students from across the country in the field of cardiovascular science. Our long-term goal is to bolster the pool of clinician-scientists in our workforce by 1) providing opportunities to increase student representation from a broad range of backgrounds 2) exposing students to the landscape of 21st century translational medicine, and 3) providing students with a strong foundation in rigor, reproducibility and the responsible conduct of research. We will work toward the first of these goals by partnering directly with Meharry Medical College and the University of Puerto Rico to provide opportunities to highly-qualified medical students from their institutions to obtain research experiences with Stanford faculty. Our program is open to all, and applicants undergo a rigorous and unbiased application review process. After recruiting a broad and well-qualified cohort of medical students, we will provide our trainees with a comprehensive ten-week curriculum that will prepare students for careers as physician-scientists in cardiovascular medicine. 80% of trainee time will be devoted to a cardiovascular research project in the lab of a Stanford physician-scientist faculty mentor. The remaining 20% of their time will be spent in a comprehensive curriculum comprised of seminars in cardiovascular science, research training, physician-scientist career development opportunities and social events. To accomplish the second of our goals, preparing trainees for innovative research in translational medicine, students will be exposed to scientific opportunities that are especially enriched at Stanford. First, Stanford has a strong track record of pioneering next generation cardiovascular research in precision medicine. Second, Stanford is located in the Bay Area biotechnology hub and many of our faculty mentors can share their experiences on collaboration with industry. Third, Stanford faculty mentors lead numerous cardiovascular clinical trials that students will be able to learn from. Precision medicine, industry collaborations, and familiarity with clinical trials are all important components of the research endeavors for the next generation of physician-scientists. To accomplish our third goal of providing trainees with a strong foundation in rigor, reproducibility and the responsible conduct of research, we will provide a dedicated curriculum to address these topics under the guidance of leaders in the fields of research ethics and the philosophy of science. The program’s success and longevity will be monitored and improved upon through a robust plan for internal and external evaluation. The Program Directors and faculty mentors for this T35 have ongoing state-of-the-art cardiovascular research programs spanning basic, translational, clinical, and population level domains. Together they have the mentoring expertise and the available resources to support this T35 summer research program, which will train a qualified and committed cohort of medical students from a broad range of backgrounds to become responsible, collaborative, and innovative physician-scientists.

Public health relevance
With the rise in the impact of cardiovascular disease on US and world health, it is critical to train the next generation of physician-scientists in translational cardiovascular research. Participation in mentored research provides valuable training and increases the likelihood that medical students will continue to pursue research as part of their careers. This multidisciplinary T35 Cardiovascular Summer Research Training Program for Medical Students is designed to train a cohort of medical students from a broad range of backgrounds in basic, clinical, translational and population level cardiovascular science, to provide them with a strong foundation of medical ethics, and to foster their development into investigators dedicated to identifying innovative solutions and capable of translating basic research into clinical success to combat cardiovascular disease.